Validation of small vessel vascular contributions to cognitive impairment and dementia (VCID) biomarkers

Project Summary/Abstract
Our site at Johns Hopkins University is the lead site for the cerebrovascular reactivity(CVR)
MRI biomarker kit that will be clinically validated in the MarkVCID 2 Study. CVR MRI requires an
apparatus consisting of carbon-dioxide (CO2) monitor, gas bag, three-way valve for connection
to the gas bag, non-rebreathing valve for control of the flow of the inhaled and exhaled air, and
other accessories needed for CO2 gas delivery and sampling. The JHU site will purchase these
components to build a “startup kit”, and will ship them to the enrollment sites. This will allow the
enrollment sites to begin the data acquisition. Future replacement or ordering of components and
supplies will be the responsibility of the individual site. In this Administrative Supplement, we will
order these components, develop the “startup kits”, and ship them to the enrollment sites.

Public health relevance
Project Narrative Assessment of small vessel vasodilatory function requires certain components that will allow the delivery of carbon dioxide enriched gas to the participant while recording their lung carbon dioxide levels. We will purchase and develop an apparatus for these procedures and will provide them to the enrollment sites within the Consortium.